Administrative Core

Project Summary/Abstract Section – ADMINISTRATIVE CORE
The overarching goal of the Administrative Core of the Northwestern University (NU) Core Center for Clinical Research (CCCR) is to support and organize our team of teams, i.e., the network that represents our CCCR, and to optimize Center function and outcomes. This Core is responsible not only for CCCR management and operations, but also for specific CCCR missions. For organized and dedicated efforts to achieve these missions, we propose 3 Working Groups: the Mentoring Working Group will take charge of scientific and career development of mentees, mentor development, and team cohesion; the Outreach, Dissemination, and Enrichment (ODE) Working Group will take charge of communication, ODE activities, and expanding the Research Community and fields of work; the Evaluation Working Group will be responsible for ongoing quality and productivity assessment of CCCR activities, leveraging excellence in this area within NUCATS (NU Clinical and Translational Sciences Institute, NU’s CTSA). We will integrate the activities of the Community Advisory Board (CAB) and Methodologic and Resource Cores. Steering, Oversight, and External Advisory Committees will provide advisory support. These committees will include members with expertise in relevant diseases and conditions, methodologies, and in management of core facilities. Administrative Core aims are: 1) provide the CCCR structure tailored to a) our vision of community engagement, interdisciplinary science, and methodologies best supporting clinical research, and b) Core/CAB workflow to ensure their integration and synergy; 2) provide a structure that will sustain effective and efficient CCCR operations; 3) provide expertise and leadership to identify important projects and harness the CCCR to help them, maintaining highest rigor; 4) promote cross-Core/CAB and Core/CAB-Research Community interactions to foster interdisciplinary work and knowledge advancement; 5) optimize communication, cooperation, and collaboration among stakeholders, CCCR investigators, and scientists at NU and elsewhere; 6) foster training and development of researchers, and support development of applications for independent funding; 7) expand CCCR influence and contributions to our environment by disseminating opportunities to use the Cores: 8) disseminate knowledge, empowering our Research Community, the scientific community, Chicagoland communities, and the community at large; 9) evaluate to a) help ensure that each Core is at the forefront to best position it to contribute to innovation, and b) assess outcomes of our CCCR’s work prospectively, using a priori designated metrics that incorporate team science instruments; 10) lead an initiative including surveys and a workshop collaborating with the other CCCRs and stakeholders, with the goal of better defining, capturing, and communicating the meaningful impacts of the work that is enabled by the CCCRs; 11) ensure that a data and resource sharing plan is implemented by each component of the CCCR.